Neural-Epithelial Encoding of Airway Senses

PROJECT SUMMARY/ABSTRACT
Airway sensory neurons communicate physiological and environmental cues to the brain, including inhaled
gases, irritants, and lung volume. Subtypes of sensory neurons cooperate with specialized epithelial cells to form
discrete sensory modules, with the potential to regulate neighboring cells and tissue function. Yet, little is
understood about the properties of many neural-epithelial sensory sites and their underlying signaling
mechanisms. Understanding the underlying pathways of neural-epithelial communication in the airways will offer
new insights into the physiological control of respiration and answer fundamental questions about neural-
epithelial interactions. Sensory innervation of the respiratory tract is largely derived from the vagus nerve, the
major sensory connection between the internal organ systems and the brain. In the lung, clusters of
neuroendocrine cells termed neuroepithelial bodies (NEBs) are innervated by vagal sensory neurons marked by
P2ry1-ires-cre, providing a neuro-epithelial conduit to modulate pulmonary activity. NEBs have been proposed
to detect various stimuli, including hypoxia, airway stretch, and inflammatory cues, but little is known about the
diversity, response properties, and physiological functions of NEB cells.
This proposal will interrogate NEB sensory properties by a) gaining access to NEBs using mouse genetic tools,
b) imaging approaches to directly interrogate the responses of NEBs in situ, c) cataloging the sensory repertoire
of NEBs, and d) state-of-the-art neuroscience tools to dissect the underlying vagal neurocircuitry. These powerful
tools will allow me to selectively activate and ablate NEBs in vivo, remotely control associated vagal sensory
neurons, target candidate molecular transducers, and measure how these perturbations regulate respiratory
physiology. My independent research aims will provide mechanistic insight into defining both the molecular and
cellular components that orchestrate sensory responses to airway stimuli, thereby helping illuminate the role of
NEBs in pulmonary physiology.
My preliminary data and the environment in the Liberles Lab provide strong evidence for the feasibility and
validity of this approach, which combines cellular and in vivo model systems. The Liberles Lab has discovered
distinct subsets of vagal sensory neurons, profiled a “vagal atlas” to identify unique neuronal subtypes, and
extensive expertise in surveying sensory biology in airways. This proposed training plan supports my long-term
goal to expand our understanding of sensory neural circuits and how they transduce distinct stimuli, thereby
providing a new mechanistic framework for interactions between neurons and ‘sentinel’ cells, like NEBs. The
proposed experimental approaches build on my background in immunology and cellular physiology with new
training in neuroscience and pulmonary physiology from my outstanding mentorship team. This award will further
support my professional and scientific training as I develop a unique and independent research program.

Public health relevance
PROJECT NARRATIVE Sensory neurons control breathing and airway defense in response to changes in the air we breathe, inhaled irritants, and internal stressors with the help of unique connections to other airway cells. I am using powerful genetic tools and state-of-the-art neuroscience approaches to determine what senses are detected by these specific neurosensory sites and how they control lung function. This study will help reveal how sensory cells detect changes in our lungs, thereby offering new insights on basic sensory pathways in the airways.